Human Cancer Virology

UWCCC Human Cancer Virology (VR) Program
Co-Leaders: Shannon Kenney and Rob Kalejta
PROJECT SUMMARY / ABSTRACT
Viruses cause at least 15% of human cancers. In the VR program, we study how viruses infect, replicate, persist,
and cause tumors, as well as how we can prevent, diagnose, and treat virally-induced cancers. Our 17 highly
collaborative members study all 7 human tumor viruses, play significant leadership roles in the University of
Wisconsin Carbone Cancer Center (UWCCC) as well as the McArdle Laboratory for Cancer Research, and
derive great benefit from UWCCC colleagues, shared services, and pilot funding. We recruited 4 new members,
our externally awarded funding has increased every year since 2017, and >90% of our faculty members have
active extramural funding. The program project grant (P01CA022443) that supports many of our investigators
was renewed for years 41-45 with a perfect priority score of 10. Our two-way community engagement and
outreach has expanded, and we continue to be a driving force in training the current and next generation of
cancer biologists and virologists, and in promoting diversity, equity, and inclusivity initiatives. Previously we
received an Exceptional to Outstanding rating, attenuated from Exceptional only by a desire for more intra-
programmatic publications and translational work, and because we had yet to participate in a clinical trial. Since
that rating, we have increased our intra-programmatic publications by 63%, and reinvigorated our translational
work into a thriving and expanding pipeline resulting in one current and one future clinical trial. Our significant
achievements, and our clear plans to sustain and advance our important mission, are detailed in the Specific
Aims and Research Strategy pages that follow.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.